EUCOMM Conditional Vector and ES Cell Clone Collection (Year 24 Supplemental)

EUCOMM Conditional Vector and ES Cell Clone Collection
Acquisition and Procurement Plan by the MMRRC at UC Davis
ABSTRACT
The Mutant Mouse Resource and Research Center at the University of California, Davis (MMRRC) is pleased
to submit this administrative supplement for support during the current grant year (ending January 31, 2025) in
response to EMAIL . This application proposes the procurement and acquisition of data, molecular vectors,
and ES cell clones for 2,751 genes targeted as knockout-first alleles produced by the EUCOMM project at
Helmholtz Zentrum Munich for the original EUCOMM Program. These genes are unique to the set of
conditionally-targeted genes produced by KOMP2 as part of the International Mouse Phenotyping Consortium
(IMPC), are not already in the MMRRC, and are not readily available and accessible by the US research
community. Further, because the US research community continues to actively express interest in mouse
models expressing conditional alleles for use in their NIH-funded R01 research and other scientific projects,
ensuring availability and access to the EUCOMM collection is paramount. However, support for the
maintenance and preservation of this collection is being discontinued which puts their future availability for
research in jeopardy despite their continued use and interest. The cost to transfer ownership and stewardship
of this resource is a very small fraction (~3%) of what it would cost to recreate it using CRISPR-mediated
gene-targeting in ES cells. Once fully imported and incorporated into the MMRRC, the collection would be
available for distribution to the biomedical research community, especially NIH funded investigators who
continue to express interest in conditional, lacZ tagged alleles. As a result of the activities funded by this
administrative supplement, procurement and acquisition of the EUCOMM conditional alleles will exert a
sustained, powerful influence on research field(s) using conditional mouse models and the overall ORIP
mission to support a variety of resource and research centers that develop animal models of human biology
and disease for biomedical researchers not only in the US, but around the world. The costs to execute this
project are beyond the available support provided by the parent MMRRC grant to UC Davis. If awarded, funds
will be used to complete this project during the current grant year (ending January 31, 2025). A budget of
$534,139 total direct costs ($681,529 total costs) is requested to fund activities that all fall within the scope of
the parent award.

Public health relevance
EUCOMM Conditional Vector and ES Cell Clone Collection Acquisition and Procurement Plan by the MMRRC at UC Davis PROJECT NARRATIVE The Mutant Mouse Resource and Research Center (MMRRC) at UC Davis provides the research community with scientifically unique and valuable mouse resources to support biomedical studies into understanding human health and disease. A particularly important collection of conditional alleles from the EUCOMM project at Helmholtz Zentrum Munich are not readily available to the US research community, and are at risk of loss. Acquisition and procurement of this set of conditional vectors and alleles in ES cells will enhance the services provided by the MMRRC.